PHARMACOLOGIC STUDIES ON THE CORONARY CIRCULATION

Pharmacologic approaches to the suppression of platelet function have received growing attention in recent years due to the recognized role of platelets in the early stages of intravascular thrombosis. To-date most information concerning the ability of drugs to suppress platelet reactivity has been derived from studies using in vitro or ex vivo methods of aggregometry and minimal data exist with respect to the in vivo effectiveness of pharmacologic interventions in the prevention of coronary artery thrombosis in response to intimal injury of the coronary vascular bed. The present proposal will employ a conscious canine model of coronary thrombosis developed and validated in this laboratory. The model will be used to explore the acute and chronic effects of drugs which suppress platelet function in response to vascular wall injury and to determine if in vivo test results correlate with ex vivo aggregometry determinations of platelet responsiveness. Studies are designed to explore the potential ability of thrombolytic agents to restore coronary blood flow after varying intervals of thrombotic occlusion of the left circumflex coronary artery and to assess the consequences associated with coronary reperfusion. Additional studies in the acute anesthetized dog will serve to determine if various pharmacologic agents, known to alter platelet reactivity, can effect the coronary hyperemic response to brief periods of ischemia and to regional administration of arachidonic acid and/or bradykinin. The studies will be supplemented by gross morphological and electron microscopic observations on the affected coronary artery segments. These investigations should provide basic data which are needed to design and interpret future clinical trials intended for the prevention of coronary artery thrombosis and for the purpose of reversing coronary artery occlusion due to intravascular thrombosis. Most significant is the fact that the proposed model, represents the first conscious ambulatory animal model in which coronary thrombosis occurs in response to endothelial injury and allows for a rational approach to the development of antithrombotic and thrombolytic agents which heretofore has depended largely upon in vitro or acute animal model test prodedures.